Role of miR-6236 in Obesity-Associated Adipose Tissue Dysfunction

PROJECT SUMMARY/ABSTRACT
This proposed two-year project stems directly from studies and career development activities related to my
current K08 (DK116668), and represents a new research direction that will enhance my advancement towards
independence through the generation of preliminary data and publications to support an R01-level application
on how adipose tissue macrophages (ATMs) influence adipose tissue homeostasis and organismal metabolism.
During the first two years of my K08 award I published multiple papers, obtained a tenure-track assistant
professorship at the University of Pennsylvania (Penn), and initiated my independent research program at
Children’s Hospital of Philadelphia (CHOP). With the continued mentorship of Dr. Mitchell Lazar and my K08
advisory committee, my independent research lab has grown dramatically in its first year and now numbers six
full-time research staff, graduate students, and post-docs. I have obtained independent foundation support for
my lab, and an NIH supplement to study the role of ATMs in HIV-associated metabolic dysfunction. We have
published our first fully-independent (senior author) research manuscripts, and I have been invited to speak at
multiple national conferences. My lab is now ready to accelerate our research program in ATMs in preparation
for the transition to R01 funding.
My R03 proposal focuses on understanding how a novel, ATM-secreted microRNA (miR-6236) influences
adipocyte functions and organismal metabolism in the context of obesity. miR-6236 is both a novel miRNA, and
the most highly expressed and highly secreted ATM miRNA. To facilitate our studies of this molecule, we have
developed two novel transgenic mouse models that allow for whole organism or tissue-specific loss-of-function
of miR-6236 in vivo. Whole body deletion of miR-6236 leads to increased weight gain, and impaired glucose
control in the context of obesity. We have also developed in vitro models that preliminarily suggest that miR-
6236 controls mitochondrial respiration in adipocytes. Together, these data support our primary hypothesis that
miR-6236 protects against obesity and it’s sequela by influencing how ATMs function in, and interact with, their
tissue environment. We will test this hypothesis by crossing an established miR-6236 LoxP mouse line to the
LysM-Cre most strain, effectively deleting miR-6236 in the myeloid immune lineages. The goal of this proposal
is to comprehensively phenotype the effects of myeloid-specific miR-6236 deficiency on the adipose tissue
macrophages, adipocytes, and mammalian metabolism. This work is a natural extension of my K08, and will act
as a paradigm for future studies of ATM-secreted miRNAs in my lab. Importantly, this proposal will support the
generation of publications and preliminary data for an R01-level application in this field.

Public health relevance
PROJECT NARRATIVE Despite established roles in regulating adipose tissue homeostasis and obesity-related outcomes, the molecular mechanisms by which adipose tissue macrophages (ATMs) influence metabolic health are still being elucidated. This proposal uses a new mouse model to study the most abundant member of the ATM microRNA secretome (miR-6236). Studying miR-6236 functions in the context of obesity will elucidate one pathway by which ATMs exert their functions in adipose tissue to influence mammalian metabolism.